Regulation of Macrophages in Obesity-Enhanced Breast Cancer

The development of certain subtypes of breast cancer (BrCA) in postmenopausal women is largely influenced by non-genetic factors such as high fat diet (HFD)-induced obesity. The pathophysiological mechanisms that link obesity to BrCA risk include inflammatory processes; adipose tissue macrophages (ATMΦs) are a primary source of inflammation, however, there has been little mechanistic evaluation of their specific role in BrCA. There is evidence to confirm a regulatory role of miRNA-155 on MΦ-induced inflammation; it has been shown that miRNA-155 directly inhibits suppressor of cytokine signaling 1 (SOCS1) in MΦs, thus increasing their inflammatory potential. While it is clear that miRNA-155 can positively regulate MΦ-induced inflammation, there is a fundamental gap in the understanding of its role on the regulation of ATMΦ-induced inflammation in HFD enhanced BrCA. The long-term goal is to understand the role of ATMΦs in HFD enhanced BrCA that will lead to the development of behavioral and or medical treatments that are clinically relevant. The objective of this particular investigation is to determine the role of ATMΦs on inflammation and subsequent progression of HFD enhanced BrCA, and further, to evaluate if this process is regulated by miRNA-155. The central hypothesis is that the regulation of ATMΦ-induced inflammation in HFD-enhanced BrCA is mediated through miRNA-155. The rationale for the proposed research is that elucidating the molecular mechanisms linking obesity to BrCA will translate to a more effective prevention/treatment approach. This hypothesis will be tested by pursuing two specific aims: 1) Determine the role of ATMΦs on inflammation and subsequent progression of BrCA; and 2) Evaluate the role of miRNA-155 on regulation of ATMΦ-induced inflammation in BrCA. Under the first aim we will examine the effect of a HFD that closely mimics the standard American diet on BrCA progression in the PyMT mouse model of BrCA, and will examine the association between BrCA, adipose tissue inflammation, MΦ polarization, and expression of miRNA-155. Further, using adoptive transfer of ATMΦs from wild-type mice fed a HFD to BrCA mice fed a low fat diet (LFD) we will directly determine the role of ATMΦs on progression of BrCA. In the second aim, we will test the hypothesis that miRNA-155 plays a critical role in the regulation of MΦ-induced inflammation in HFD enhanced BrCA. To this end, using a PyMT X miRNA-155-/- mouse we will examine the role of miRNA-155 on ATMΦ-induced inflammation and subsequent tumorigenesis. Further, using adoptive transfer of ATMΦs from HFD miRNA-155-/- mice to PyMT mice that will be fed a LFD we will determine if the effects of ATMΦs on BrCA progression are mediated through miRNA- 155. The innovation of this investigation is anchored in the examination of the role of ATMΦs in BrCA, and further, the regulation of these MΦs by miRNA-155. The proposed investigation is significant as it addresses prevention of incidence and progression of HFD-enhanced BrCA. If this hypothesis is correct miRNA-155 may be an important therapeutic target of ATMΦ-induced inflammation in HFD-enhanced BrCA.

Public health relevance
PROJECT NARRATIVE Inflammation has been implicated as a link between obesity and breast cancer. Adipose tissue macrophages are a primary source of inflammation; however, mechanistic evaluation of their specific role in the progression of breast cancer is limited. The overall goal of this proposal is to gain an understanding of the role and regulation of adipose tissue macrophage-induced inflammation in obesity enhanced breast cancer that could be targeted in future investigations using behavioral and or medical treatments. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Brief Statement of the Problem: High-fat diet (HFD)-induced obesity increases the risk for certain subtypes of breast cancer (BrCA) in postmenopausal women1-31. A pathophysiological mechanism that may link HFD- induced obesity to BrCA risk is chronic inflammation 1, 2, 4, 32-50. Adipose tissue macrophages (ATMΦs) are a primary source of inflammation 51-53 and are known to influence obesity-enhanced BrCA; however, there has been little mechanistic evaluation of their exact role in BrCA. Evidence from our laboratory shows that administration of an inhibitor for MCP-1, an important chemokine for MΦ recruitment that is increased with HFD feedings, results in reduced tumorigenesis and decreased MΦ markers implicating a role of MΦs in the development of BrCA. In addition, we have data to show that HFD feedings can increase pro-inflammatory MΦs in adipose tissue, which is associated with increased tumorigenesis. Furthermore, exciting new data generated by our laboratory shows that adoptive transfer of ATMΦs increases inflammation in a mouse model of colitis. Micro-RNAs (miRNAs), a class of non-coding RNAs are involved in regulating several aspects of the inflammatory response. It has been shown that microRNA-155 (miR-155) inhibits signaling pathways in MΦs that can suppress inflammation 54, 55. It is upregulated during the MΦ inflammatory response and has been implicated in playing a role in the link between inflammation and cancer 55, 56; however, this has not yet been substantiated in vivo. While there are several studies that have linked miRNA-155 to BrCA 55, 57-62, there are no reports of a role of miRNA-155 in HFD- enhanced BrCA. Recently we have made an exciting observation that miRNA-155-/- mice fed a HFD have a significant reduction in the number of ATMΦs. Further, we have new data to show that miRNA-155-/- mice have reduced tumor number and decreased symptom severity in a chemically-induced mouse model of colorectal cancer. Given the hypothesized link between ATMΦ-induced inflammation and BrCA progression and our findings of a reduced number of ATMΦs in miRNA-155-/- mice, it is certainly possible that regulation of ATMΦ-induced inflammation by miRNA-155 may influence HFD-enhanced BrCA. The overarching goal of this proposed study is to determine the role of ATMΦs on inflammation and subsequent tumor progression in HFD-enhanced BrCA, and further, to determine if this process is regulated by miRNA-155. The central hypothesis is that the regulation of ATMΦ-induced inflammation in HFD- enhanced BrCA is mediated through miRNA-155 (Figure 1). Statistically powered in vivo studies utilizing the PyMT mouse model of BrCA 63, that will be fed a HFD to induce obesity, will test this hypothesis under two related aims. Aim 1. To determine the role of adipose tissue macrophages on inflammation and subsequent progression of breast cancer In this aim, we will examine the effects of a HFD that mimics the American standard diet on tumor progression in the PyMT mouse model of BrCA and will relate this to changes in MΦ polarization, inflammation and expression of miR-155. Further, using adoptive transfer of ATMΦs from wild-type mice fed a HFD to BrCA mice fed a low fat diet (LFD) we will directly determine the role of ATMΦs on progression of BrCA. Aim 2. To evaluate the role of miR-155 on the regulation of adipose tissue macrophage-induced inflammation in breast cancer We will test the hypothesis that miR-155 plays a critical role in the regulation of ATMΦ-induced inflammation in HFD enhanced BrCA. Using a PyMT X miR-155-/- mouse, we will examine ATMΦ-induced inflammation and subsequent tumorigenesis. Further, using adoptive transfer of ATMΦs from HFD miR-155-/- mice to PyMT mice that will be fed a LFD we will specifically determine if the effects of ATMΦ-induced inflammation on BrCA progression are mediated through miR-155. This proposal is of critical public health relevance; it will allow for an understanding of the regulation of MΦ- induced inflammation in HFD-enhanced BrCA, a process that is thought to be at the mechanistic core of this disease and that could be targeted in future investigations using behavioral and or medical treatment.